Harmony AI: State of the Art Natural Language Processing for Genetic Engineering

Project Summary/Abstract:
Computational techniques for gene engineering, such as codon optimization, use synonymous
codon changes to increase protein production. Applications for these computational gene
optimizations include recombinant protein drugs, nucleic acid therapies, and mRNA vaccines.
Although codon optimization increases protein production in certain systems, synonymous
changes to a gene sequence can cause unexpected detrimental results to the protein. Further,
researchers have been critical of codon optimization for human therapeutics as the optimization
process can affect protein conformation and function, and reduce efficacy. Therefore, codon
optimization may not provide an optimal strategy for increasing protein production or designing
safe and effective therapeutics. CFDRC has utilized state-of-the-art natural language processing
techniques to learn how synonymous codons are used by a target organism and apply this learning
to gene engineering. We demonstrated our model could predict the E. Coli synonymous codon
usage with 73% accuracy, significantly above prior reports. We believe that using this AI-based
approach to gene engineering will provide an optimal strategy for increasing protein production
and may increase the efficacy of therapeutics.

Public health relevance
Project Narrative: Computational approaches to gene engineering are a critical aspect of many fast-growing industries, including recombinant protein manufacturing, gene therapies, and mRNA vaccines. Recently, researchers have been critical of the gold standard approach to gene engineering, codon optimization, as the optimization process can affect protein conformation and function, and reduce efficacy. CFDRC has utilized state-of-the-art natural language processing techniques to learn how synonymous codons and apply this learning towards gene engineering to provide an optimal strategy for increasing protein production and efficacy of therapeutics.